Predicting Pancreatic Ductal Adenocarcinoma PDAC Through Artificial Intelligence Analysis of Pre Diagnostic CT Images in African Americans

The objective of this administrative supplemental proposal is to demonstrate that a specific model is
needed to improve the accuracy of predicting Pancreatic Ductal Adenocarcinoma (PDAC) risk in
African Americans through Artificial Intelligence (AI) analysis of pre-diagnostic CT images. PDAC is the
fourth leading cause of cancer-related deaths in both men and women in the United States despite its low
incidence rate. PDAC has a high mortality rate in part because more than 80% of the patients are at advanced
stages when they were diagnosed for the first time. Notably, there are significant racial disparities in PDAC
incidence and mortality rates, with the highest rates in African Americans compared to Non-Hispanic
Whites and Hispanics. The objective of the parent award is to develop a PDAC prediction model to identify
individuals who have high risk for PDAC in the next 10 years through AI analysis of pre-diagnostic CT images.
Identification of individuals at high risk for PDAC has high clinical significance as follow-up imaging
examinations or biopsy may assist in early detection and allow surgical intervention while the tumors are still
resectable. Pre-diagnostic CT images provide critical morphological information associated with underlying
biological changes and heterogeneity at the pre-cancer or early cancer stage. A pilot study using data from the
parent award identified a number of different radiomic features in pre-diagnostic CT scans that are predictive of
future PDAC between African Americans and Whites. Based on these studies, we hypothesize that: i) pre-
diagnostic CT image features associated with future PDAC occurrence are significantly different between
African Americans and Whites; ii) CT radiomic model developed for the general population in the parent award
is less accurate in African Americans than in the general population for PDAC prediction. To verify these
hypotheses, we will retrospectively evaluate CT pancreatic images obtained up to 10 years prior to PDAC
diagnosis that were deemed non-cancerous by radiologists. A group of subjects who underwent similar
imaging studies for non-gastrointestinal disorders and were age/gender matched with pre-diagnostic imaging
will serve as healthy controls. Pre-diagnostic CT radiomic features will be compared between African
Americans and Whites. If they are significantly different, we will demonstrate that the CT radiomic
model developed for the general population in the parent award is less accurate in African Americans than in
the general population for PDAC prediction. The purpose of this administrative supplemental proposal
pilot study is to demonstrate that there is need for a specific PDAC prediction model through AI
analysis of pre-diagnostic CT images for African Americans to improve the PDAC prediction accuracy.
Accurate prediction of PDAC has high clinical impact as it may allow early detection and treatment of this fatal
disease, which has the highest rates of incidence and mortality in African Americans.

Public health relevance
Pancreatic Ductal Adenocarcinoma (PDAC), a common type of pancreatic cancer, is the fourth leading cause of cancer-related deaths in both men and women in the United States. The goal of the proposed project is to develop an artificial intelligence algorithm based on computed- tomography scans to identify individuals at high risk for PDAC in African Americans, which may allow early detection of PDAC and increase survival rate.